Osteoarthritis: Quantitative Evaluation of Whole Joint Disease with MRI

Project Summary
Osteoarthritis (OA) is an enormous clinical problem and worldwide cause of disability.
Development of new therapies for OA is hampered by a lack of sensitive imaging tests that
respond to changes in disease status. Recently FDA and CE approved clinical knee 7T MRI has
the potential to add sensitivity and specificity to advanced MRI biomarkers of OA progression.
This project will compare changes seen at 3T and 7T across two different vendors systems and
assess the potential for 7T MRI to improve our ability to study and develop new disease-
modifying therapies. This study will enhance future studies and clinical exams at 7T and can be
used to improve routine 3T MRI though machine learning reconstruction and enhanced
understanding of OA disease mechanisms. Understanding the relative strengths of 3T and 7T
MRI in this important clinical application is critical to developing new disease-modifying
treatments for patients with OA.

Public health relevance
Narrative Osteoarthritis affects more than half of the population during their lives and is the leading cause of disability worldwide. Diagnostic imaging of osteoarthritis is often limited to x-ray, but more sensitive and specific imaging is a critical need for development of disease-modifying treatments. This work aims to develop novel 3D imaging approaches using 3T and 7T magnetic resonance imaging (MRI), to quantitatively assess joint health across different tissues in osteoarthritis.